Enrichment Program

Project Summary – Enrichment Program
The Enrichment Program of the Nutrition Obesity Research Center (NORC) at the University of North Carolina at Chapel Hill (UNC) is designed to foster the exchange of knowledge and ideas among faculty members, trainees, research staff, and the community at large while increasing the general public’s awareness of nutrition and obesity research at UNC and beyond. These activities span basic science, epidemiologic research, intervention research, translational science, and nutrition- and obesity-relevant community engagement and policy. Activities include but are not limited to seminars, workshops, symposia for a variety of audiences, as well as nutrition education for physicians. The goals of the Enrichment Program are to create an engaging educational program to foster interdisciplinary collaborations, to provide training opportunities to foster the development of early career investigators and to educate the general public about the UNC NORC and the importance of nutrition and obesity research.